Mechanisms of a therapeutic DNA vaccine targeting Mycobacterium tuberculosis persisters

PROJECT SUMMARY
Host status plays a major role in tuberculosis (TB) disease outcomes, with many efforts to develop host-directed
therapies to boost immune response. It is unknown how these strategies will perform in people living with
HIV/AIDS (PLWHA) who are at increased risk of adverse TB treatment outcomes. Persistent Mycobacterium
tuberculosis (Mtb), which obligates prolonged TB treatment, highly expresses the stringent response protein
RelMtb. One attractive host-directed therapeutic strategy is boosting RelMtb-specific cellular responses. We
developed a novel therapeutic DNA TB vaccine that promotes immune responses to RelMtb, which are further
enhanced by fusion with a chemokine gene, Macrophage Inflammatory Protein-3 alpha (MIP-3α), that targets
relMtb to immature dendritic cells (DCs). Our data show that an intranasal (IN) or intramuscular (IM) DNA vaccine
expressing MIP-3α/relMtb (“fusion” vaccine) demonstrated greater adjunctive therapeutic efficacy when combined
with the first-line TB treatment in Mtb-infected mice as compared to IM vaccination with relMtb alone (“non-fusion”
vaccine). This proposal will dissect the mechanisms of this novel therapeutic strategy, specifically with IN
administration which had the highest efficacy. We will also test whether this strategy is likely to perform in
PLWHA, analyzing whether RelMtb-specific immune responses in PLWHA can predict therapeutic TB outcomes.
Aim 1 will investigate the molecular mechanism by which the IN administration potentiates anti-TB drugs, while
Aim 2 will focus on the role of DCs in the adjunctive therapeutic efficacy of the fusion vaccination strategy. Aim
3 will test the translational potential of the RelMtb-specific T-cell immunity in PLWHA. In Aim 1, we test if IN
vaccine administration enhances the host response to Mtb infection through increased IL-17A secretion. We will
perform single-cell transcriptomics on cells from murine lungs to confirm the upregulation of IL-17A response
pathways in the IN arm, followed by Mtb-infected IL-17A knockout murine experiments. In Aim 2, we hypothesize
that the IN fusion vaccine leads to more efficient systemic and local T-cell maturation, activation, and
differentiation through enhanced DC activation compared to the IN non-fusion vaccine. Aim 2a will assess
differences in DC activation by flow cytometry, DC and T-cell co-localization in murine tissues, and differences
in T-cell activation/differentiation using co-culture experiments with DCs derived from each vaccination group. In
Aim 2b, we will adoptively transfer DCs from mice immunized with either vaccine into Mtb-infected mice
concurrently with TB treatment to compare the adjunctive therapeutic efficacy. In Aim 3, we hypothesize that
RelMtb-specific Th1/Th17 cell responses in peripheral blood mononuclear cells derived from HIV-infected and
uninfected patients receiving treatment for pulmonary TB, correlate inversely with sputum culture conversion and
TB recurrence rates, independently of HIV status. The proposed studies will uncover critical details of the
mechanism of a novel therapeutic vaccination approach against TB with important implications in PLWHA and
help the PI to gain significant expertise in TB/HIV immunology.

Public health relevance
NARRATIVE We developed a novel therapeutic tuberculosis (TB) vaccine that potentiates the efficacy of the traditional, prolonged TB treatment. With the mechanistic studies described in this proposal, we will dissect the multifaceted immune response to TB, offering shorter treatment and alternative options to standard TB treatment when adverse drug reactions, resistance, recurrence, or treatment failure complicate clinical management, especially in high-risk populations, including patients living with HIV. Understanding how our TB therapeutic vaccine works can serve as proof-of-concept for targeting other key TB-related enzymes and treating other chronic infections.